The Role of Engagement in the Efficacy of Mindfulness Training for Adolescents

Project Summary/Abstract
Experiencing mental health problems during adolescence is associated with symptom worsening and
recurrence later in life, as well as poorer physical health and increased risk for preventable chronic diseases.
Mindfulness-based intervention (MBI) has been shown to support key skills and capacities that may protect
against mental health challenges, including emotion regulation (ER) and mindfulness. Yet, MBI effects on health
and wellbeing outcomes in adolescents are generally small and inconsistent across studies. Theory and
empirical evidence suggest that engagement, a multidimensional construct referring to the degree of productive
involvement with an activity, may be a key change process underlying the effect of MBI on target intervention
processes (i.e., ER and mindfulness). The proposed study will be the first to rigorously test engagement as a
mechanism of MBI in adolescents. The specific aims are to (1) Test longitudinal and time-ordered change
associations for engagement and target processes (ER and mindfulness) and (2) Utilize an embedded,
sequential mixed-methods design to identify factors that facilitate and impede adolescent engagement in MBI.
These aims will be tested in N=75 community adolescents participating in a single-arm trial of MBI on mental
health and stress physiology. The current proposal is a novel extension of the parent study that incorporates
longitudinal structural equation modeling and mixed methods to conduct a mechanistic examination of
adolescent engagement in MBI. The proposal is designed to advance the candidate’s long-term career goal of
leading research that deepens our understanding of the mechanisms of MBI and strengthens the science of its
implementation, ultimately through supporting communities in effectively implementing and evaluating MBI for
themselves. The training objectives are to: a) Develop the skills to analyze repeated measures to rigorously test
engagement as a mechanism of MBI, b) Gain training in the integration of qualitative and quantitative data to
more deeply understand MBI engagement, and c) Develop expertise in designing, implementing, and sustaining
community-based research on mindfulness and adolescent health. The findings generated through this work will
provide preliminary insights into the role of engagement in MBI efficacy for adolescents, an important step toward
identifying pragmatic directions to optimize MBI for the prevention of adolescent mental health challenges. The
training and development activities will enable the candidate to launch her career as an independent scientist,
capable of effectively collaborating with communities to conduct research on MBI for the prevention of adolescent
health challenges and the promotion of holistic wellness.

Public health relevance
Project Narrative Mindfulness-based intervention (MBI) may be an effective avenue for preventing adolescent mental health challenges; however, to maximize its potential requires a deeper understanding of processes underlying MBI efficacy. The proposed study will conduct a mechanistic investigation of the role of engagement (i.e., the degree of productive involvement in an activity) in adolescent MBI through examining the longitudinal, time-ordered change associations between engagement and target processes of MBI (e.g., emotion regulation and mindfulness), as well as integrating qualitative data with quantitative findings to identify facilitators and barriers to engagement. Findings may provide important directions for individuals involved in the development and delivery of MBI in terms of leveraging engagement to support adolescents in deriving maximal benefit from MBIs.